Structure and Function of Protein Disorder in Membrane Trafficking and Organization

Project Summary/Abstract
Intrinsically disordered proteins and protein regions (IDPs and IDRs) lack stable tertiary structure but retain
biological function. Understanding the structure/function relationships of IDPs/IDRs presents a significant
challenge because of their variable and dynamic nature. Recently, an increased awareness and recognition of
the prevalence and roles of IDPs and IDRs in membrane trafficking and organization has emerged. The
primary goal of the proposed research is to advance our understanding of how the dynamic and highly variable
structure of IDPs mediates their functions in membrane trafficking and organization. A key aspect of IDP
function in membrane trafficking and organization involves direct IDP-membrane interactions, which occur in
conjunction with disorder-to-order transitions, or in the absence of protein ordering. Formation of membrane-
binding amphipathic helices (AHs) is a common example of the former, but the mechanisms underlying and
regulating the formation, stability, specificity and function of such membrane-associated AHs remain poorly
understood. Factors that govern membrane binding by IDRs that remain disordered in the bound state are
even less well understood. A major area of proposed research centers on delineating mechanisms for these
types of IDP-membrane interactions using proteins such as alpha-synuclein, metabotropic glutamate receptors
and complexins as models via a combination of in vitro characterization of structure and dynamics and in vivo
functional assays. Another emerging aspect of IDP function is their ability to mediate formation of condensates
or membraneless organelles. Recently, it has been demonstrated that IDR-containing membrane-binding
proteins can form cytosolic condensates that sequester and organize intracellular reservoirs of membrane
vesicles. The mechanisms that regulate the ability of condensates to interact with and organize membranous
vesicles or compartments have barely been explored and represent second major focus of this proposal. The
primary model system for these efforts will be the clustering of membrane vesicles mediated by the protein
synapsin, and the regulation of this clustering by IDPs/ IDRs such as synucleins and rab proteins. Efforts will
also include investigating the role of condensate formation in the organization of tubulo-vesicular organelles
such as the endocytic recycling compartment. These systems will be characterized using structure/function
analyses combining in vitro characterization of condensate formation and vesicle recruitment/release with in
situ and in vivo functional studies. Achieving the goals of this proposal will serve to advance our understanding
of different mechanisms that underlie the roles of IDPs and IDRs in the regulation of membrane trafficking and
organization. By focusing on specific models with physiological significance, namely factors governing vesicle
exocytosis, organellar contact sites, cell signaling and the formation of clustered vesicular structures in
neurons and other cell types, the results will make a significant impact on specific fields as well as broaden our
general understanding of how protein disorder contributes to the organization of cellular membranes.

Public health relevance
Narrative: Intrinsically disordered proteins are a recently recognized class of proteins that do not fit classical structure/function paradigms, but participate in fundamental physiological processes. The prevalence and role of such proteins in mediating and regulating critical membrane trafficking and organization pathways required for cell function and survival is only now becoming appreciated. This project aims to clarify mechanisms that link the structural and dynamical properties of disordered proteins to their ability to regulate membrane fusion, organellar contacts, cell signaling and intracellular membranous compartments.